SWOG NCTN BIQSFP Supplement for GY11

This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding
Program (BIQSFP) funding for the following SWOG Cancer Research Network studies:
S1608, S1803, S1827, S2114, S2212, S2306 and S2312 (NEW) .
Additionally, this request contains the progress reports for the following additional studies:
S1418, S1602, S1612, and S1826.

Public health relevance
This is a supplement application for Biomarker, Imaging and Quality of Life Studies Funding Program (BIQSFP) funding for the following SWOG Cancer Research Network studies: S1608, S1803, S1827, S2114, S2212, S2306 and S2312 (NEW) . Additionally, this request contains the progress reports for the following additional studies: S1418, S1602, S1612, and S1826.